Probing the Role of Secondary Lymphoid Tissue Architecture in HIV-1 Associated NLRP3 Inflammasome Signaling

Human immunodeficiency virus type 1 (HIV-1) infection can lead to both acute and chronic states of inflammation
in people with HIV (PWH), even in the setting of effective viral suppression with antiretroviral therapy (ART).
Dysfunctional and hyperactive inflammation in PWH is associated with an accelerated aging phenotype that
results in increased risk for severe sequelae like neurocognitive impairment and atherosclerotic cardiovascular
disease. Development of targeted anti-inflammatory therapies capable of synergizing with existing ART regimens
to reduce the long-term burden of HIV disease is limited by a gap in knowledge of the specific molecular
mechanisms underlying HIV-associated immune activation. Studies of HIV-1 infection in the lymphoid
environment have revealed inflammatory signaling distinct from that in the periphery, prompting the need for
methods to probe the types of immune cells directly and indirectly impacted by infection as well as the underlying
inflammatory signaling pathways. We have developed a human tonsil tissue explant histoculture model of HIV-
1 infection in which intact tonsil tissue blocks preserve the full native architecture, cellular repertoire, and milieu
of lymphoid tissue, and therefore many of the associated cell-cell interactions and functions. Intriguingly, unlike
in peripheral blood, abortive HIV-1 infection in lymphoid tissues can cause pyroptosis, a highly inflammatory form
of programmed cell death mediated by the NLRP3 inflammasome, affecting bystander cells adjacent to HIV-1
infected CD4+ T cells. This proposal seeks to test the overarching hypothesis that the architecture of intact
human lymphoid tissue supports the close apposition of HIV-1 infected CD4+ T cells to activate NLRP3
inflammasome signaling and IL-1ß release in bystander myeloid cells. Aim 1 will evaluate how the presence or
absence of lymphoid tissue structure affects HIV-1 infection and inflammatory signaling by comparing intact
tonsil tissue with dissociated cell suspensions for differences in cell types, gene expression, and cytokine
production. Aim 2 will interrogate the spatial and functional relationships within lymphoid tissue that facilitate
NLRP3 activation and generate a molecular morphologic atlas of the HIV-exposed tonsil. This innovative
approach, combining single-cell sequencing and spatial transcriptomics with an ex vivo human tonsil model of
HIV-1 infection, can yield insights into the innate immune mechanisms driving dysfunctional inflammation in
PWH. This work will take place within the Icahn School of Medicine at Mount Sinai (ISMMS) in the Mount Sinai
Health System. Between the Department of Medicine Division of Infectious Diseases, Department of Immunology
and Immunotherapy, and Center for Advanced Genomic Technology, I am supported by over 100,000 ft2 of
research programs and an additional 4500 ft2 of institutional core facilities, in addition to over $200 million in
scientific computing resources such as the Minerva supercomputer. Together, this fellowship leverages the
resources of my institution and the expertise of my sponsor to support my training in four key areas: 1) scientific
excellence, 2) mentorship, teaching, leadership, & advocacy, 3) professional development, and 4) clinical skills.

Public health relevance
Human immunodeficiency virus type 1 (HIV-1) infection leads to both acute and chronic inflammatory states even with effective antiretroviral therapy, increasing risk for life-threatening comorbidities associated with accelerated aging, such as neurocognitive impairment, metabolic lipodystrophy, and atherosclerotic cardiovascular disease, among people with HIV. Yet, the specific mechanisms that cause systemic inflammation among people with HIV remain unknown, and thus targeted anti-inflammatory therapies are not available to mitigate the long-term inflammatory consequences of chronic HIV infection. The proposed research may identify the precise immune signaling pathways in ex vivo human tonsil tissue underlying HIV-associated inflammation, with the potential to not only inform the development of novel anti-inflammatory therapeutic classes, but also to uncover fundamental insights into the immunologic basis of aging-associated illnesses with broader public health impact.